BoostPrime, A Novel Digital Therapeutic for Craving Mitigation in OUD

PROJECT SUMMARY
The National Institute on Drug Abuse indicates that “there are more deaths, illness, and disabilities from
substance use than from any other preventable health condition.” In SUDs, and particularly opioid use disorder
(OUD), individuals frequently experience uncontrolled craving symptoms, even receiving treatment under a
supervised medication for OUD program (MOUD, also known as MAT) including supportive psychotherapy and
peer recover services. In addition, individuals with SUDs are noted to have impairments in self-control
cognitive processes. We propose to address cravings burden and to strengthen momentary (seconds/minutes
range) self-control processing by delivering an adjunctive solution, “BoostPrime”, as a smartphone-based
software intervention for craving support, incorporating novel cognitive training exercises. With multiple lines of
preliminary research establishing Boost platform cognitive training effects and symptomatic benefit for high
utilizers, and indicating viability for clinical deployment commercially, we will now: refine the operator interface
and system design to accommodate utilization-enhancing strategies for patients and providers; and engage the
FDA to inform regulated development and validation plans. In Phase II we will conduct large-scale human
testing of platform variants to inform an optimal utilization-enhancement strategy (i.e., an adaptive model)
which will be tested in a pivotal study of patients receiving MOUD treatment support in an outpatient setting; for
craving benefits and momentary self-control improvements. Activities will culminate in De Novo submission of
the BoostPrime digital therapeutic package to the FDA, as an adjunctive treatment for cravings in OUD.

Public health relevance
PROJECT NARRATIVE Opioid use disorder (OUD) and related substance use disorders are highly damaging to individuals and society. Cravings and self-control are key contributors to OUD relapse which remain underserved by current treatments/tools. We propose to develop and validate a customized digital therapeutic software intervention to address these issues (“BoostPrime”) for FDA approval/clearance as medical device.